Training and Dissemination

SUMMARY/ABSTRACT (TRAINING & DISSEMINATION)
Magnetic resonance (MR) techniques have become indispensable in studies of organ function in health and
disease, using advanced instrumentation, complex auxiliary capabilities, such as large-scale data and image
processing, and complementary measurements employing other techniques (e.g., electrophysiology) and/or
other imaging modalities such as single and multiphoton imaging. The optimal use of these techniques, however,
requires access to new methods that enable new measurement capabilities (such as new MR pulse sequences)
and require extensive training. The general aim of this Training and Dissemination component of this P41
National Center for Biomedical Imaging and Bioengineering (NCBIB) is to educate scientists in the technologies
we develop in the NCBIB and disseminate the many products and information that will result from the activities
of the Technology Research and Development projects. The training activities will focus on continuing education
and advanced training in high and ultrahigh field MR imaging and spectroscopy methods, UHF instrumentation,
and multimodal imaging for biomedical research and clinical use. The goal is to catalyze broad application of
NCBIB tools and skill sets by a national community of basic, translational, and clinical investigators thereby
increasing the Center’s impact. This goal will be accomplished through workshops, hands-on training courses,
publications and conference presentations, and a comprehensive web site providing information and access.